Hypertension and Cardiorenal Research Training Program

Hypertension has long been recognized as a major risk factor for cardiovascular diseases, including coronary artery disease, heart failure and stroke, and for ESRD. In the southeastern United States, and especially in Mississippi, cardiovascular and renal diseases occur much more frequently than in the rest of the country. The objective of the multidisciplinary Hypertension and Cardiorenal Diseases Research (HCDR) Training Program is to recruit, train, and mentor pre-doctoral and postdoctoral students in cardiovascular and renal research so that they become the next generation of researchers in this field.

Public health relevance
Hypertension has long been recognized as a major risk factor for cardiovascular diseases, including coronary artery disease, heart failure and stroke, and for ESRD. In the southeastern United States, and especially in Mississippi, cardiovascular and renal diseases occur much more frequently than in the rest of the country. The objective of the multidisciplinary Hypertension and Cardiorenal Diseases Research (HCDR) Training Program is to recruit, train, and mentor pre-doctoral and postdoctoral students in cardiovascular and renal research so that they become the next generation of researchers in this field.